Thalamic Circuits Underlying Opioid Seeking

Prescription opioid abuse is the fastest growing drug problem in the United States. Now, deaths from overdose of opioid pain relievers exceed those from all illegal drugs. Chronic opioid use induces opioid dependence, which is characterized by extremely unpleasant physiological and psychological symptoms after drug use is terminated. Opioid users learn to associate opioid intake with relief from negative physical and affective states. This maladaptive association might last long after withdrawal has terminated and underlie the drug cravings experience by many users after exposure to drug-­associated cues or stressful life events. We have recently identified that the paraventricular nucleus of the thalamus (PVT) is a prominent neuronal substrate mediating the physical signs and negative emotion accompanied with opioid withdrawal, which provide a unique opportunity to directly examine the contribution of withdrawal states to opioid-­associated memories. In this application, we propose to use pathway specific optogenetic and pharmacogenetic manipulation (1) to determining roles of the PVT output pathways in the formation and maintenance of opioid-­associated memories;? (2) to study morphine induced plasticity in each PVT pathway and impact of pathway silencing on this plasticity;? (3) we will combine pathway specific manipulation in the PVT, c-­Fos iDISCO+, and light sheet fluorescent microscopy to mapping brain-­wide network activities underlying opioid-­associated memories. Our work will inspire the development of novel strategy to treat opioid abuse.

Public health relevance
Opioids’ potent euphoric effects and excessive withdrawal symptoms make them the most commonly abused prescription drug. In this proposal, we use viral, optogenetic, pharmacogenetic and electrophysiological tools and behavioral assays to examine the anatomical and functional organization of a newly identified circuitry that mediate opioid dependence, and delineate the contribution of this circuitry to the formation and maintenance of opioid-associated memories. Results from propose work will provide new insights for the development of novel drugs or therapeutic strategies to treat opioid abuse.